Circuit Engagement in Prosthetically Driven Retina

PROJECT SUMMARY
Blindness caused by photoreceptor death, as in Retinitis Pigmentosa and Age related Macular
Degeneration, is among the leading causes of irreversible blindness in the world today. Retinal
prosthetics are currently the only vision restoration therapy available for these patients but results so far
have been modest. To design more effective retinal prosthetic devices, we need a better understanding
of how prosthetic stimulation activates diseased retinal circuitry to perform basic visual computation.
The premise of this proposal is based on the observation that inhibition is an integral part of retinal
signaling yet remains poorly understood in the context of retinal degeneration and vision restoration. This
leaves us with an incomplete understanding of how retinal degeneration changes visual processing
circuits. Here we will identify how inhibitory signaling is altered by retinal degeneration and determine
how these changes alter the processing of prosthetic visual information during clinically relevant patterns
of electrical stimulation. This proposal is innovative, because we use a unique combination of single
cell electrophysiology techniques, combined with custom fabricated multielectrode arrays consisted with
current devices used in clinical trials.
The results from this proposal will be significant and will: 1.) Determine optimal stimulation
strategies to restore vision in a range of vision restoration technologies. 2.) Uncover basic physiological
mechanisms that determine how spared retina responds to electrical stimulation, and 3.) Determine how
prosthetics can engage basic computational circuitry in diseased retina to extract temporal contrast
information from spatiotemporal patterns of electrical stimulation. These experiments will produce
needed insight into the fundamental mechanisms underlying early visual computation and guide
strategies to improve the design and execution of retinal prosthetic devices. The long-term goal of this
work is to improve the design and implementation of retinal prosthetics for vision restoration, ultimately
improving the quality of life for a broad patient population.

Public health relevance
NARRATIVE A significant portion of patients suffering from irreversible blindness could benefit from prosthetic vision restoration. We can design better retinal prosthetics if we understand how electrical stimulation from subretinal prosthetics activates early retinal circuits, and if we understand how spared computational circuits are altered during retinal degeneration. The results from this proposal will inform biologically rational strategies for stimulating retina to maximize vision restoration.